Exploiting Water Network Perturbations in Protein Binding Sites

PROJECT SUMMARY/ABSTRACT
Water enables life. So much so that the search for extraterrestrial life is a search for liquid water. However,
terrestrial drug discovery still, by and large, ignores water molecules. The reason lies in the complexity and
versatility of its contributions to biomolecular interactions, despite its apparent simplicity. My prior research has
investigated the role of water in ligand recognition and selectivity, and its utility to improve ligand discovery.
Recently, my lab has established a link between the mobility of water networks and the affinity of ligand binding
to proteins. More generally, the work highlights the exploitable sensitivity of water networks in response to
changes in protein and ligand. My long-term goal is to link atomic-scale water wiggles to changes in the protein
conformational landscape and ultimately to organismal fitness. To achieve this, I aspire to pave the path to a
more dynamic view of protein function that integrates currently neglected aspects of protein flexibility and
hydration. This is important because cryogenic structures, which make up 95% of the Protein Data Bank,
deliver a contorted, static image which is then used to design ligands. The objective of the proposed work is to
formulate a pragmatic framework that defines and utilizes water network dynamics. As water is ubiquitously
found at all biological interfaces, the concept extends beyond protein-ligand interactions to many fields,
including protein-protein interactions, allostery, protein evolution and resistance.
My central hypothesis is that we can use the exquisite sensitivity of water molecules to contextual changes in
our favor. The hypothesis that water fluctuations report on changes in dynamic features will be exploited in
three specific areas via perturbation with 1) temperature, 2) mutation and 3) ligands. 1) Re-defining water
networks in protein structures: I hypothesize that physiological temperatures provide a less distorted view of
water networks within protein crystals than structures obtained using common cryogenic freezing. We will test
the hypothesis by solving crystal structures of proteins over a range of temperatures. By exposing freezing
artifacts, we can reveal hidden changes in water network dynamics that can be used productively to predict
binding affinities. 2) Exploring isoform-specific differences in water networks: I hypothesize that by using water
perturbations as a reporter for change, we can distinguish near-identical Hsp90 isoforms. We will test the
hypothesis by tracking how co-evolved water networks respond to perturbations in a context-dependent
manner. This will expose subtle differences in isoforms that the Hsp90 field has struggled to exploit for
decades to explore differential isoform biology in disease. 3) Considering water network dynamics in ligand
discovery: I hypothesize that including experimental water network terms will improve computational docking.
Based on our previous success of including computationally derived solvation energies, we expect that this will
lead to novel Hsp90 ligands that minimize water perturbation, which cannot be discovered otherwise.

Public health relevance
Project Narrative This proposal explores untapped potential for turning water network perturbations from a nuisance into an exploitable reporter of protein-ligand interactions. The work will re-define structural water features using variable temperature crystallography and implement a smooth, experimental water term into computational docking to distinguish and selectively target highly similar protein isoforms. By using a water-centric approach at physiological temperature we can overcome current limitations of protein-centric, cryogenic approaches that have failed to produce an FDA approved drug for disease-promoting molecular chaperones despite decades of intense research.